Project 2: Treating metastatic lung cancer by targeting mutated KRAS with engineered T cells

Project Summary/Abstract – Project 2
Lung cancer of which ~85% are histologically non-small cell lung cancer (NSCLC) is still the leading cause
of cancer deaths among men and women in the U.S. and worldwide. More than 50% of cases have distant
rather than localized disease at diagnosis, with ~6% 5-year survival rate. The development of precision drugs
that target mutated driver oncogenes has yielded high response rates, improved survival, and reduced toxicity
compared to classical chemotherapy. However, virtually all patients develop drug resistance via mechanisms
such as acquiring additional mutations in the oncogene target or activation of downstream signaling pathways.
Immunotherapy is an orthogonal strategy for treating NSCLC. Immune checkpoint inhibition (ICI), initially
approved for NSCLC in 2015, has provided therapeutic benefit by blocking inhibitory signals to activate
immune responses in patients. However, responses are rarely durable and occur in only a minority of patients,
with most responses lasting ~1 year. This reflects in part the specificity of the elicited T cell responses, which
predominantly recognize non-truncal mutations not associated with oncogenicity, and failure of many tumors to
attract and/or to actively block immune responses. An alternative immunologic strategy has been to generate
and expand tumor-reactive T cells in vitro, and then infuse large numbers back into the patient. This approach
has proven very effective in melanoma, and proof-of-principle studies have affirmed it is feasible in NSCLC.
Our lab has been developing cell therapies for viral and malignant diseases for several decades, with a
current focus on genetic engineering. Principles to reproducibly achieve tumor eradication have emerged,
including targeting antigens essential to the tumor, providing durable T cell responses, and overcoming
obstacles to T cell activity. We propose combining synthetic biology with cell engineering to address each of
these obstacles. First, we will engineer both CD4 and CD8 T cells to function with the same Class I-restricted
TCR and be specific for mutated KRAS, the most common oncogenic driver in NSCLC, thereby creating a
coordinated CD4 and CD8 T cell response that can sustain anti-tumor activity. Second, we will use multi-omics
technologies to generate high dimensional data sets describing events in the blood and at the tumor site to
illuminate reasons for success and/or resistance. Third, we will develop next generation strategies to enhance
efficacy by engineering T cells to express synthetic molecules that convert inhibitory and/or death signals to
costimulatory and survival signals to promote durable T cell responses. The specific aims are:
1) Evaluate in a Phase I trial safety and activity/efficacy of autologous CD8 and CD4 T cells transduced to
express an A11-restricted, high affinity, mKRASG12V-specific TCR and CD8ab chains in A11+ NSCLC patients.
2) Assess, using multiomics technologies, the immunobiology of the transferred T cells pre- and post-
infusion and the impact the T cells have on the tumor as means to elucidate obstacles interfering with efficacy.
3) Evaluate next generation strategies for broadening and enhancing efficacy of T cell therapy in NSCLC.

Public health relevance
Project Narrative – Project 2 Lung cancer remains the leading cause of death in men and women from cancer in the US as well as worldwide. Precision drugs that target genetic changes in cancer cells that drive the cancer have significantly improved outcomes and reduced toxicity of treatment, but ultimately virtually all patients become resistant to these drugs and the cancer progresses. Immunotherapy is an orthogonal treatment, and we have developed methods that employ synthetic biology to engineer T cells to target the most common cancer driver and to establish durable immune responses in patients for mediating sustained anti-tumor activity that can potentially eradicate the tumors; thus, we propose developing a new effective treatment strategy for lung cancer patients.